Multispectral imaging of bile duct epithelial morphology for early detection of malignancy

Project Summary
Bile duct cancer, also known as cholangiocarcinoma, is the second most common primary liver cancer. It
is considered to be an incurable cancer with no identifiable risk factors, that can rapidly become lethal,
unless it can be detected early enough to be fully resected. Cross-sectional imaging lacks sensitivity to
cellular structure and biochemical properties of the bile duct wall. While a combination of endoscopic
retrograde cholangiopancreatography (ERCP) based brush cytology and trans-papillary endobiliary
forceps biopsy, which is often considered the gold standard, has a high specificity, it offers only low
sensitivity. Another very significant challenge with the current standard of care approaches is difficulty in
acquiring tissue samples adequate for the histopathologic examination. Because of the poor prognosis, a
technique capable of reliably detecting pre-cancer of the bile duct is urgently needed. We recently
introduced a new diagnostic technology that combines light scattering spectroscopy and diffuse
reflectance spectroscopy to identify biliary duct pre-cancer and early cancer during routine diagnostic
ERCP procedures. It employs a single-point forward looking ultraminiature spatial gating fiber optic
probe. To ensure clinical acceptance of the technique and improve accuracy, scanning the entire internal
surface of the bile duct in a shorter time using an ERCP catheter-compatible probe, without the
requirement for a cholangioscope, would be a major advance. Therefore, we propose to develop a side
looking spatial gating fiber optic probe capable of parallel data collection at multiple locations on the bile
duct wall to significantly simplify and speed up the operation of the clinical system. We will test the
performance of the new endoscopic instrument in detecting bile duct pre-cancerous and early cancerous
lesions in patients undergoing ERCP for potential malignancies as well as inflammatory strictures and
gallstones.

Public health relevance
Project Narrative Bile duct cancer, the second most common primary liver cancer, is considered to be an incurable cancer with no identifiable risk factors that can rapidly become lethal, unless it can be detected early enough to be fully resected. Because of the poor prognosis, a technique capable of reliably detecting pre-cancer of the bile duct is urgently needed. We propose to employ the minimally invasive endoscopic light scattering spectroscopy technique for rapid data collection from the entire internal surface of the bile duct and identification of bile duct pre-cancer and early cancer.